CArdiometabolic riSk and Comorbidities in Adults with Down syndrome- Electronic Health Record Examination (CASCADE)

Project Summary
Despite their well-recognized increased risk of overweight and obesity, adults with Down syndrome (DS) have not
traditionally been considered at increased risk for “cardiometabolic” conditions such as Type 2 diabetes (T2D) and
atheromatous disease. Recent robust epidemiologic data from the UK Clinical Practice Research Datalink suggest
adolescence and young adulthood are specific periods of vulnerability for T2D development in this population.
Overweight and obesity are clear risk factors, but their intersection with both DS-related co-morbidities [obstructive
sleep apnea (OSA), congenital heart defects (CHD), dementia, hypogonadism, cancer survivorship] and
demographics [race/ethnicity, aging] recognized to confer increased cardiometabolic risk (CMR) remain undefined.
An improved understanding of CMR as well as potentially cardioprotective factors in a large, diverse population of
individuals with DS is crucial for defining screening practices and interventions that minimize patient burden while
considering the relevance of both traditional T2D complications and the intersection of CMR with established DS-
related co-morbidities.
This study will leverage de-identified data from a large,
Research
diverse population of adults with DS captured in the TriNetX
Network of multiple health care organizations to 1) describe the prevalence of T2D, dyslipidemia,
hypertension, OSA as well quantify HbA1C and lipids (HDL, LDL, TC, TG) by 5-year intervals; 2) examine the
relationships of T2D, atheromatous disease, and dyslipidemia with common co-occurring condition in adults
with DS (history of CHD, overweight/obesity, OSA, psychiatric medication prescription, dementia, menopause,
cancer survivorship) and demographics (age, sex, race/ethnicity), 3) explore microvascular complications in the
subset of patients with diabetes and 4) quantify screening practices for co-occurring conditions in adults with DS.
This large database effort performed in a diverse, national population of adults with DS will advance our
understanding of the prevalence of CMR, vascular complications, and cardiovascular risk factors in DS, a critical
step for developing screening guidelines and targeted interventions that minimize patient burden without
compromising care. This work will serve as the foundation for a longitudinal study aimed at defining the relevance
of T2D and CMR for individuals with DS and to develop interventions to optimize screening for co-occurring
conditions.

Public health relevance
Project Narrative This study will use a large, insurance claims-electronic medical record database to estimate prevalence of multiple co-morbidities in a diverse, national population of adults with Down syndrome. In addition to diagnoses, the study will examine labs, available physical assessments, and orders used to screen for co-occurring condition in Down syndrome. This work will serve to better understand co-morbidities and screening practices in adults with Down syndrome.